Developing an ultra-high throughput droplet microfluidic workflow for genetic circuit characterization

PROJECT SUMMARY
Existing single cell sequencing technologies provide an unprecedented understanding of the unique genomic
and transcriptomic differences that underlie heterogeneous biological samples. These differences are key to
understand disease pathologies in clinical samples and fundamental mechanisms in basic biological
applications. Recent attention has been directed towards the development of multiomic technologies that better
capture the differences in paired datasets such as genome and transcriptome or transcriptome and
epigenome. Currently however, there is no single cell technology that can profile sequence information with the
corresponding phenotypic behavior of the cell.
The purpose of this project is to develop a novel sequencing platform to address this technology gap. To
demonstrate the utility of this platform, I will then apply it to rapidly characterize a tunable genetic oscillator.
To accomplish this goal, I propose the following 2 specific aims. In Aim 1, I will develop FAB-seq
(Fluorescence Annotated Barcoding and Sequencing). I will first demonstrate a novel dual barcoding
approach that co-delivers optical and DNA barcodes to create single cell maps between microscopy image
data and sequence data. I will also show that FAB-seq can be used to perform targeted sequencing according
to an arbitrary phenotype. Then, I will leverage additional injected DNA barcodes to enhance the total barcode
space of FAB-seq. In Aim 2, I will then demonstrate that FAB-seq can be used to rapidly characterize a tunable
genetic oscillator. First, I will demonstrate that FAB-seq can detect oscillatory phenotypes from a circuit library
containing oscillatory and non-oscillatory genetic circuits. Then I will show that when the oscillatory behavior of
the circuit is perturbed, FAB-seq can map individual oscillation dynamics to the corresponding single cell
transcriptome.
The long-term goal of this project is to develop a platform technology that can map single cell microscopy data
to single cell sequencing data at ultra-high throughput. I envision FAB-seq to be a transformative tool in
addressing questions at the frontier of the genomics field.

Public health relevance
PROJECT NARRATIVE Single cell sequencing technologies are incredible tools for characterizing differences in the sequence of cells in a heterogeneous sample. Many questions on the frontier of genomics consider not only the difference in the sequence of these cells, but also how the sequence encodes differences in the phenotype of the cells. This work aims to develop a novel sequencing technology that can simultaneously profile the phenotype and sequence of individual cells, opening the door to entirely new research questions previously unaddresable.